IMMUNOLOGY AND PATHOLOGY OF MURINE LEUKEMIA VIRUS INFECTIONS

The purpose of this project is to investigate the genetics and immunology of resistance to retroviral infections; both innate resistance and induced reistance are studied. Specifically, we use mice infected with Murine leukemia viruses as models to examine immunological resistance mechanisms and mechanisms of vaccine protection. Genetically defined mouse strains such as congenic, congenic recombinant, transgenic, and knockout strains are used to identify resistance genes, and to relate genetic resistance to specific immunological mechanisms. In addition, we also use these mice to investigate mechanisms of vaccine-induced protection against both acute disease and persistent retroviral infections. The work basically involves determining which types of cells are involved in protective responses versus the types of cells involved in non-protective or even harmful responses, and determining what these various cells are doing. - Friend virus, Erythroleukemia, Immunosuppression, Vaccines, T cells, Antibody, Retrovirus, Mice Persistent virus, Genetic resistance